Progressing Bend Health’s Digital Rapid Crisis Support for Adolescents and Caregivers

1 PROJECT ABSTRACT
2 Self-injurious thoughts or behaviors (SITBs) have sharply increased among adolescents in the past
3 decade. In the U.S., 3.7 million adolescents have seriously considered suicide and 2.9-9.6 million have self-
4 harmed. Adolescent SITBs not only pose serious short- and long-term health risks for adolescents, but also
5 impose significant economic and emotional burdens on their caregivers. While digital mental health interventions
6 (DMHIs) have proven successful for various pediatric mental health issues, most commercial DMHIs do not
7 address adolescent SITBs, and none provide concurrent care for caregivers. Despite evidence that peer support
8 groups and caregiver involvement can improve treatment outcomes, no DMHI currently offers a comprehensive,
9 age-appropriate approach to adolescent SITBs that addresses the social and economic costs across all
10 populations.
11 Bend Health is a pediatric digital mental health care provider for over 5,500 children, adolescents, and
12 their caregivers and is the one of the very few commercially-available DMHIs that includes adolescents who
13 exhibit SITBs. Bend Health’s current SITB treatment is a remote rapid crisis support team (RCST) paired with
14 therapy and behavioral health coaching. Despite its positive impact on outcomes, it lacks comprehensive
15 caregiver and peer support, which are critical components shown to improve treatment retention and overall
16 effectiveness. Additionally, it has not been rigorously tested in a randomized controlled trial (RCT), limiting the
17 evidence base necessary for broader adoption and standardization in clinical practice.
18 In Phase I, with input from caregivers and adolescents with lived SITB experience, we will develop peer
19 and caregiver content to maximize Bend’s existing RCST. We will assess the more comprehensive RCST-Max
20 by conducting an 8-week feasibility study with 30 adolescents and their caregivers, assessing key metrics such
21 as recruitment, retention, engagement, and user satisfaction. Phase II will involve a RCT comparing the
22 enhanced RCST-Max to the existing RCST in 344 adolescents, with the goal to demonstrate that RCST-Max
23 can increase engagement and retention, reduce SITB risk, decrease emergency service utilization, improve
24 comorbid anxiety and depressive symptoms, and enhance parent-adolescent communication and caregiver well-
25 being. This study aims to establish the clinical and commercial value of a comprehensive DMHI for SITBs,
26 promoting its adoption by healthcare providers and addressing the significant social and economic costs
27 associated with adolescent SITBs.

Public health relevance
PROJECT NARRATIVE Self-injurious thoughts and behaviors (SITBs) in adolescents are at an all-time high in the U.S. and have significant economic and health impacts on both adolescents and their caregivers, but most commercial digital mental health interventions do not address adolescent SITBs. This project will leverage a commercially-available digital mental health care service, Bend Health, to add peer and caregiver support to an already-existing and effective rapid crisis support team to maximize the impact of the intervention. We will use perspectives from adolescents and caregivers with lived experience to inform the development of the prototype, which will then be tested for patient feasibility and acceptability, and then tested for efficacy in a randomized control trial.